Support Activities of the ARP in National Cancer Institute

This contract is in support of the Applied Research Program within the Division of Cancer Control and Population Sciences at the National Cancer Institute.